Mechanistic characterization of quantitative trait genetics affecting cell metabolism

Natural variation in DNA sequences between individuals occurs as a result of mutations over
time. Variations in DNA sequence can lead to differences in the ultimate outcome, or
phenotype, of the individual carrying these genetic variants. Using the model yeast
Saccharomyces cerevisiae, our group has identified regions of the genome in which differences
in DNA sequence result in heritable differences in the level of specific proteins that are made by
genes distinct from the changed regions. Our focus is on changes to protein levels that occur
independently of changes in expression of the mRNAs that code for these proteins. We will
identify the specific base-pair changes in DNA sequence that are responsible to better
understand the mechanisms by which changes in DNA lead to changes in the level of other
proteins. Many of the proteins we found to be regulated in this way are necessary for the
uptake and catabolism of glucose by cells. We will specifically identify which DNA sequences
lead to different rates of glucose uptake in order to understand how glucose transporters are
regulated. We will also use mass spectrometry chemical analysis to measure the contents of
cells and determine whether these changes in protein level lead to changes in the growth of
cells, or alternatively whether some of these differences are a way by which cells enact
metabolic homeostasis.

Public health relevance
Natural variation in DNA sequences between individuals occurs as a result of mutations over time. Genetic variation can lead to differences in the ultimate outcome, or phenotype, of the individuals carrying these different sequences. Natural variation in some regions of the genome results in heritable differences in the level of proteins that are made by genes located far from the varying sequences, suggesting the presence of variation in regulators of protein abundance. Many of the proteins regulated in this fashion are involved in allowing cells to take up and metabolize nutrients. This project will examine the mechanisms linking genetic variation to how cells regulate the level of metabolic enzymes and other proteins in order to better predict the phenotype of cells based on DNA sequence.